Electrowetting Droplet Microfluidics for Biochips

DESCRIPTION (provided by applicant): The increased interest in pharmaceutical, chemical, and biomedical/genetic analysis and diagnostics has led to the development of numerous micro-electromechanical systems (MEMS) based fluid handling and mixing systems. The majority of these systems is based upon either the employment of continuous-flow systems, or provide for discrete sample manipulation through the use of external, macro-scale, appliances (e.g., syringe pumps, centrifugal acceleration field, etc.). In contrast to these approaches, we propose to develop a platform to manipulate individual droplets using an electrically addressed control system. Utilizing the Electrowetting Effect, the solid-liquid surface energy will be manipulated using a microfluidic platform formed from an array of controllable electrodes. Decreases in the solid-liquid surface energy cause a corresponding decrease in the contact angle at the liquid-solid-vapor line, resulting in a pressure imbalance between the two ends of the droplet, causing the droplet to move. Tanner Research, Inc. and the Keck Graduate Institute (KGI) are proposing to develop enabling technology, utilizing electrowetting arrays, for motion control of sub microliter sized droplets. Within the Phase II effort, Tanner Research, Inc. and KGI will develop a revolutionary EW-ActiveSlide(tm) R&D platform: a complete, high-density electrowetting array and control system, capable of addressing the growing niche of investigative microfluidic research and development, through a reconfigurable, user-friendly platform. The development and automated execution of DNA hybridization studies and DNA amplification through EXPAR will be demonstrated, both in solution and with surface immobilized DNA strands. Commercial applications for the proposed electrowetting-based microfluidic research and development platform include high-integration, high-throughput, lab-on-a-chip systems for genomics, proteomics and lab automation. The EW-ActiveSlide(tm) would initially be targeted as a laboratory research tool, and will therefore be compatible with existing commercial fluorescence microscopy. Protocols developed on the platform could integrate sample preparation, aliquoting, and hybridization, developing efficient and cost effective means for screening and identifying samples. Expansion into handheld pathogen detection and identification, and to patient screening of SNPs and alleles for clinical use in estimating drug efficacy, will be pursued as a second-stage marketing effort in Phase III.